Training in Environmental Toxicology of Human Disease

Environmental Health Sciences at the University of Arizona has a long-standing reputation for
excellence in training Ph.D. and postdoctoral scientists, as evidenced by the fact that many of our
graduates are leaders in academia, industry, and government. To this end, our graduate program
has evolved from a systems-based toxicology experience to a curriculum in which students are
trained to apply state-of-the art techniques to solve mechanisms of environmental toxicity
affecting human diseases in various organ systems. The cutting-edge research programs of 30
Training Grant Faculty members are augmented by innovative technologies developed at the
University of Arizona in association with the Southwest Environmental Health Sciences and BIO5
Centers. Additionally, translational approaches undertaken by our NIEHS Superfund Program
and Dean Carter Binational Center for Environmental Sciences and Toxicology provide an
exceptionally stimulating environment for the training of graduate students and postdoctoral
fellows. The interactive research of our Training Grant Faculty and our state-of-the-art Facility
Cores extend the training environment from a single laboratory-oriented domain to a
multidisciplinary experience strongly supportive of collaborative research. Current trainees are
now selected through a University-wide competition and the UA Graduate College provides
financial support for all first year Ph.D. students through an umbrella recruitment program,
providing a large pool of highly qualified candidates for competitive selection of predoctoral
trainees. Predoctoral training is achieved through a combination of coursework, laboratory
research, and supplemental enrichment activities. Postdoctoral trainees participate in innovative
research programs and are guided to develop professional skills in oral and written
communication and leadership. Over the past five years, our curricular changes have paralleled
the evolving expertise of the Training Grant Faculty. We have recruited eight senior full
Professors, three Associate Professors, and seven junior Assistant Professors into the Training
Grant, which significantly enhanced our core strengths in mechanistic-based molecular toxicology
training. The request for continuation of NIEHS support is justified by the highly successful nature
of our program, the clear demand for our graduates, the strong emphasis we place on leadership
skills for our trainees and postdoctoral fellows, the increasing number of students interested in
toxicology and environmental health, substantial institutional commitment, the strong and well-
funded research programs of our faculty, and the excellence of the training environment.

Public health relevance
This program is to train the future leaders in environmental toxicology who facilitate the discovery of how environmental exposures affect human health and disease. Our program focuses on mechanistic molecular toxicology and translational applications to human disease that utilize an outstanding training environment to develop exceptional environmental health science researchers.